Regulation of Tumor Invasion and Metastasis by Matrix Stiffness

Summary/Abstract
The survival of individuals with Down syndrome (DS) due to trisomy 21 has increased drastically in recent
decades, resulting in large numbers of adults with DS. Studies indicate that individuals with Down syndrome
have over 10-fold lower risk of developing breast cancer compared to the general population. The reduction of
breast cancer is significantly higher than the reduction of general solid tumors (about 2-fold) in individuals with
DS. It has long been hypothesized that chromosome 21 might contain cancer suppressor genes. However, it
remains largely unknown what these tumor suppressor genes are and specifically no unique breast cancer
suppressor genes have been uncovered. Breast tumors are often identified by manual palpation due to their
apparent “hardness” compared to normal tissue. A 10-50-fold increase in tissue stiffness in certain breast
tumors correlates with distant metastasis and poor outcome. Our ongoing studies found that rigid matrix
stiffness activates a novel mechanotransduction pathway to induce Epithelial-Mesenchymal Transition (EMT)
and promote tumor metastasis. We show that high extracellular matrix stiffness activates nuclear localization
of an EMT-inducing transcription factor TWIST1 to promote tumor invasion and metastasis. Interestingly, our
preliminary data suggest that deregulation of this mechanism due to trisomy 21 could contribute to suppression
of breast cancer development and progression. To test this hypothesis, we plan to 1) determine whether and
how inhibiting EMT by gene alternation due to trisomy 21 contributes to breast tumor suppression in human
and mouse mammary organoids; 2) determine whether and how inhibiting EMT by gene alternation due to
trisomy 21 contributes to breast tumor suppression in breast tumor xenografts in mice.

Public health relevance
Narrative/Relevance The proposed research aims to determine how mechanical forces exerted from extracellular matrix in the tumor microenvironment are translated into biochemical signals to regulate breast tumor invasion and metastasis. In this supplement application, we aim to test whether this mechanism is altered due to trisomy 21, thus contributing to ~10-fold reduction of breast cancer incidence in individuals with Down syndrome.